ANCHORAGE CAMPUS ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Infrastructure funding is provided to the College of Arts and Sciences and to the Vice-Provost for Research to assist in the support of the research enterprise.